UJMT FGHF Launching Future Leaders in Global Health (LAUNCH) Research Training Program Admin Supplement

PROJECT SUMMARY
In this supplemental application, we request funding for three U.S. postdoctoral fellows and two U.S. predoctoral
scholars who have been selected for the 2023-2024 cohort of the UJMT LAUNCH Program. The funding is
expected from four institutes, centers, or offices (ICOs) at the National Institutes of Health: NCI, NIDCD, NIDDK,
and OBSSR. Three ICOs will support one postdoctoral candidate each, while the remaining ICO is expected to
fund two predoctoral scholars. Funding includes stipend, health insurance, travel-related expenses, research,
and site support. This ad hoc funding will allow UJMT LAUNCH to expand its pool of funded trainees in the 2023-
2024 training cohort, thereby increasing the scope and impact of the overall program.

Public health relevance
PROJECT NARRATIVE The UJMT LAUNCH Program has supported pre- and postdoctoral global health research for over a decade. Supplemental funding from the National Institutes of Health has allowed our program to increase the number of supported trainees each year. This administrative supplement details the 2023-2024 training candidates with confirmed or pending ad hoc funding from participating institutes, centers, and offices within the National Institutes of Health.